Central mechanisms of glucocorticoid circadian rhythm dysfunction in breast cancer

Project Summary
Breast cancer is still the most common malignancy in women worldwide. Despite the incredible advances made
in the past decades towards eliminating breast cancer, nearly all women with metastatic breast cancer will
succumb to the disease. Therefore, we desperately need new and improved approaches towards eliminating
breast cancer. The proposed work focuses on a widely documented clinical finding with no known underlying
mechanism: blunted circulating glucocorticoid rhythms in patients with breast cancer. Critically, patients with ‘flat’
or ‘blunted’ circadian rhythms in circulating glucocorticoids (e.g., cortisol) report lower quality of life and die from
cancer earlier than patients with normal ‘robust’ circadian rhythms. Glucocorticoid rhythms are largely controlled
by concerted interactions among the hypothalamus, pituitary, and adrenal glands (i.e., HPA-axis), and act to
regulate diverse physiological processes essential for health including immune cell trafficking/polarization,
energy mobilization, arousal, and synchronization of peripheral circadian clocks. Our preliminary data
demonstrate that preclinical mouse models of breast cancer also exhibit this ‘blunting’ of the glucocorticoid
rhythm, and this is accompanied by aberrant activity within hypothalamic neurons that regulate the HPA-axis
(i.e., PVNCRH neurons). Additionally, by re-establishing a robust glucocorticoid rhythm via chemogenetic
stimulation of these neurons, we were able to significantly impede primary breast cancer growth in mouse
models. In the present proposal, we will systematically determine where along HPA-axis dysfunction occurs in
response to breast cancer, identify the mechanism(s) driving this dysfunction, and then use orthogonal
approaches to manipulate these mechanisms to confer benefits (reduced tumor and metastatic burden,
enhanced responses to checkpoint blockade immunotherapy) in mouse models of breast cancer. These studies
represent a significant step forward in our understanding of how malignant processes influence the host, and
how host responses dictate cancer progression and therapeutic efficacy. These data will further inform the design
of novel therapeutic approaches towards eliminating breast cancer by targeting the HPA-axis.

Public health relevance
Project Narrative Breast cancer remains the most common malignancy among women worldwide. Clinical work demonstrates that patients with ‘blunted’ circadian rhythms in circulating glucocorticoids (e.g., cortisol) have worse quality of life and succumb to cancer earlier than those with robust rhythms. This work will identify the mechanism(s) driving this deleterious phenomenon and develop therapeutic approaches to target it, likely conferring benefits to patients with breast cancer.